Mitochondrial heterogeneity as the origin of chemoresistance in pancreatic cancer

Summary
Therapeutic resistance and tumor relapse present as major barriers to achieving a definitive cure for cancer.
This challenge is especially relevant for patients with pancreatic ductal adenocarcinoma (PDAC), who are largely
diagnosed at advanced stages and face low survival odds. Recent studies have revealed that tumors are
complex ecosystems consisting of coexisting subclonal populations that each harbor a unique genomic
landscape. Indeed, tumors are constantly adapting in response to external perturbations such as therapeutics,
and clones capable of surviving treatment are evidence of evolved resistance to therapeutics and may provide
the foundation for relapse.
While the role of mitochondria in tumors has been largely neglected, recent studies have demonstrated
that OXPHOS can contribute to treatment resistance as well as several other processes such as invasion and
metastatization. Here, we will leverage out our novel Clonal Replica Tumors (CRTs) platform to test the
hypothesis that heterogenous mitochondrial activity across different clonal lineages plays a central role
in determining tumor response to therapy, and thus contributes to the development of therapeutic
resistance and tumor relapse in PDAC. Our CRT platform enables the testing of multiple pharmacological
disruptors or other external factors in parallel in animals bearing patient-derived xenotransplanted (PDX) tumors
with identical clonal composition. This approach allows us to explore how intra-tumor mitochondria functional
diversity is shaped by genomic heterogeneity as well as whether and how this diversity contributes to therapeutic
resistance. By focusing on treatment-naïve subclonal lineages with distinct responses to therapy isolated from
early passage pancreatic cancer PDXs, we will investigate the following aims: 1) explore the role of genomic
heterogeneity in shaping mitochondria functional diversity and define mitochondrial molecular
signatures that predict treatment response; 2) elucidate the role of mitochondria in mediating
pharmacological resistance; 3) determine the effects of targeting mitochondria on tumor clonal
architecture and construct a 3D map of tumor resistance. Ultimately, we will explore the therapeutic benefits
of targeting mitochondria to prevent therapeutic resistance and relapse in pancreatic cancer.
We are confident that our study is responsive to the NIH/NCI mission to improve patient outcomes, as it
addresses fundamental questions about how intratumoral mitochondria heterogeneity and distinct mitochondrial
phenotypes influence treatment response to drugs and sustain tumor relapse. We further anticipate that our
research will have an immediate translational impact through the identification of new biomarkers that can be
used to identify patients who may benefit from the OXPHOS inhibitors currently under clinical investigation.

Public health relevance
Narrative The proposed research is relevant for patients with cancer because it will investigate how intra-tumor mitochondrial heterogeneity influences the response to chemotherapy. The project is relevant to the NIH/NCI mission because will improve patient outcomes, as it addresses fundamental questions about the mechanisms that underlie the poor response of pancreatic cancer to current treatments. Specifically, we anticipate that our research will have an immediate translational impact through the identification of new biomarkers that can be used to select patients who can benefit from targeting mitochondrial respiration preventing tumor relapse.